Exploring Body Mass Index and Health Disparities on Lung Function Trajectories in WTC Survivors.

Project Abstract
Over two decades after the 9/11 terrorist attacks, many exposed community members in the World Trade
Center (WTC) Environmental Health Center (EHC) still struggle with ongoing airway symptoms, with functional
abnormalities in large and/or small airways as indicated by spirometry measures of airflow and/or oscillometry
measures of airway heterogeneity. Recent studies within WTC cohorts are drawing attention to the complex
interplay between WTC exposures and Body Mass Index (BMI) on lung function trajectories. Notably, the WTC
Fire Department of the City of New York (FDNY) cohort has identified BMI as the most significant metabolic
syndrome characteristic in the risk of developing WTC-related lung diseases. However, there remains a
significant gap in understanding this relationship within the WTC Survivor population, which could significantly
benefit from weight and BMI management to improve lung function and physical health. Additionally, our
unique access to oscillometry data, reflective of small airway function, provides a novel opportunity to assess
changes in lung function that may not be captured in large airway spirometry measures. Moreover, the
demographic diversity of the WTC Survivor population highlights an essential opportunity to determine the
health disparities within the WTC EHC and the critical need to address them. In this project, we propose to
tackle the important scientific questions related to BMI, lung function trajectories, and health disparities
among WTC Survivors, through the following specific aims: Aim 1: Assess the complex interplay between
WTC exposures and BMI on lung function trajectories in WTC Survivors, with a unique focus on small airway
oscillometry data. Aim 2: Utilize advanced analytics of algorithmic fairness tools and machine learning to
identify factors driving lung function trajectory disparities in WTC Survivors, particularly for BMI and related key
factors. Upon its completion, the proposed project will improve our understanding of how BMI influences the
health effects of severe respiratory diseases related to the 9/11 terrorist attacks and help develop more
effective prevention and treatment interventions that will shape equitable health policies.

Public health relevance
Narrative In this project, we propose to employ advanced statistical and machine learning techniques to investigate the complex interplay between World Trade Center (WTC) exposures after the 9/11 attacks and body mass index (BMI) on lung function trajectories in WTC Survivors, with a unique focus on small airway oscillometry data. We also aim to apply advanced analytics of algorithmic fairness tools and machine learning to identify factors driving lung function trajectory disparities in WTC Survivors, with a particular focus on BMI and related key factors, as it is critical for ensuring equitable health outcomes across the diverse WTC Survivor population. The insights gained from this study will improve our understanding of whether and how BMI influences the health effects of severe respiratory diseases related to the 9/11 terrorist attacks, help develop more effective prevention and treatment interventions, and shape more equitable health policies in the future.